Genomic reprogramming in the early embryo

PROJECT SUMMARY
Our long-term goal is to elucidate the molecular mechanisms that restructure the genome to allow for the
transition from a specified cell type to a pluripotent state. During the initial stages of embryonic development, the
genomes of the specified germ cells are rapidly and efficiently reprogrammed to generate the pluripotent cells of
the early embryo. Many features are shared between the efficient reprogramming that occurs in the early embryo
and the much less efficient reprogramming that occurs in culture. The capacity to generate pluripotent stem cells
has great potential in the modelling and treatment of disease. Understanding the fundamental molecular
mechanisms that drive reprogramming will have important implications in our ability to rapidly and reproducibly
induce the pluripotent state. Both in culture and in the early embryo, reprogramming requires the activity of
specialized transcription factors, termed pioneer factors. Pioneer factors are distinctive in that, unlike other
transcription factors, they can bind to DNA in the context of nucleosomes. This feature allows them unique
access to the genome and helps to redefine the chromatin accessibility landscape. Nonetheless, it remains
unclear what specific functions of pioneer factors are required to drive reprogramming and what the barriers are
to pioneer factor-mediated reprogramming. In Drosophila the transcription factor Zelda is required for the initial
transcriptional activation of the zygotic genome. We have demonstrated that Zelda possesses essential features
of pioneer transcription factors and that this activity is required throughout the process of zygotic genome
activation. However, Zelda is unlikely to be working independently, and we have implicated another pioneering
factor, GAGA factor, as functioning together with Zelda to define accessible chromatin domains in the early
embryo. By combining our development of novel tools to interrogate transcription factor function in the early
embryo with the strengths of the well-studied fly system, we are uniquely positioned to determine essential
features of reprogramming. We will use genetic, genomic, biochemical, and imaging strategies to 1) define how
pioneering factors cooperate to reprogram the zygotic genome, 2) identify chromatin barriers to pioneer factor-
mediated reprogramming and 3) determine the role of intrinsically disordered regions in establishing chromatin
domains in the early embryo. Our proposed research is significant because by defining essential characteristics
of pioneering transcription factors we will identify unifying principles required for efficient reprogramming of
specified cells to pluripotency.

Public health relevance
PROJECT NARRATIVE While there is immense therapeutic potential in using induced pluripotent stem cells to model and treat disease, the reprogramming of specified cells to the stem cell fate is slow and inefficient. By contrast, after fertilization the genomes of the specified germ cells are rapidly and efficiently reprogrammed to the pluripotent cells of the early embryo. Because cellular reprogramming both in the early embryo and in culture is driven by transcription factors with pioneering characteristics, we will define the fundamental molecular features of these unique transcription factors and in so doing provide insights into mechanisms required to rapidly generate stem-cell populations.